Role of macrophages and miRNA in regulating lung macrophage polarization and lung pathogenesis during respiratory virus-induced acute lung injury in normal and diabetic Syrian hamsters.

Over 25% of US Veterans have diabetes, and those Veterans are at an increased risk of hospitalization
and increased morbidity/mortality following severe respiratory viral infections, such as, influenza (H1N1), SARS-
CoV-2 (COVID) and adenovirus (Ad). Infection with these respiratory viruses causes acute lung injury (ALI) that
can result in acute respiratory distress syndrome (ARDS), with a mortality rate of ~40%. There are few
therapeutic options for ALI/ARDS. Virus induced ALI/ARDS is driven primarily by uncontrolled inflammatory
responses. Alveolar macrophages both induce and resolve ALI/ARDS, based on their polarization/inflammatory
state. The plasticity of macrophages to vary between pro-inflammatory (M1, pro-ALI/ARDS) and anti-
inflammatory (M2, anti-ALI/ARDS) phenotypes is driven by their metabolic states. Diabetes is a metabolic
disorder in which levels of blood glucose are high and glycolysis is the preferred cellular metabolic pathway.
Macrophages from diabetic patients have a high rate of glycolysis and an increased M1 phenotype. In addition,
macrophages from diabetic patients have a lower rate of plasticity to change from M1 to M2 because of this shift
to glycolysis. One possibility is that this glycolytic shift contributes to severe outcomes from respiratory viral
infections in diabetic patients.
The Syrian hamster is naturally permissive for influenza, SARS-CoV-2 and Ad (in contrast to other
rodents that require viral adaptation). In addition, the Syrian hamster can naturally become diabetic with a high
fat/high sugar diet. Ad14p1 is an emergent strain of Ad14 that has caused outbreaks of severe respiratory illness
and ALI/ARDS throughout the world. Hamster infection with Ad14p1 results in a patchy bronchopneumonia, as
seen in other severe human viral respiratory infections. In contrast, the prototype strain of Ad14 induces little
lung inflammation. Other studies have shown that cells dying from Ad14 infection induce an M2-like human
macrophage response, while cells dying from Ad14p1 infection fail to change M1 alveolar macrophages to an
M2 phenotype. This dying infected cell activity is regulated by the expression of the Ad gene, E1B 20K. Cells
infected by Ad14 produced sufficient E1B 20K to repolarize M1 macrophages to M2, while Ad14p1 infection does
not produce sufficient E1B 20K, and the infected cells fail to alter M1 macrophage polarization. Therefore, the
hamster model of Ad14p1 ALI/ARDS provides an appropriate system to study how diabetes affects macrophage
polarization and pathogenesis during severe viral respiratory infections. The long-term goal of this project is to
understand how emergent viruses regulate macrophage polarization to develop novel therapeutic strategies to
drive macrophage polarization to an ALI/ARDS resolving phenotype in both diabetic and non-diabetic Veterans.
To achieve this goal, a multi-omics approach will be used to identify and phenotype macrophages in
normal and diabetic hamsters infected with Ad14p1. Transcriptomics using single-cell RNA sequencing will use
gene expression profiles at the resolution of individual cells to identify and phenotype macrophages and their
polarization states. Infiltrating immune cells and other lung resident cells will also be identified. Proteomics will
be used to identify cytokines and chemokines that drive Ad14p1 pathogenesis. Metabolomics will be used to
understand the unique metabolic changes in the lungs during Ad14p1 infection in diabetes and how those
changes affect macrophage polarization. Comparative virology studies with infection of normal and diabetic
hamsters with a pandemic strain of H1N1 influenza will be used to determine whether similar mechanisms of
pathogenesis are involved in ALI/ARDS pathogenesis induced by other severe respiratory viruses. Finally, we
will test the role of miRNA expression during prototype Ad14 and Ad14p1 infection in regulating macrophage
polarization and pathogenesis, with the goals of defining mechanisms of immunomodulation and identifying
candidate miRNAs that might be used as therapeutic agents against viral ALI/ARDS.

Public health relevance
More than 25% of Veterans have type 2 diabetes compared with 8% in the general population in the U.S. Diabetic Veterans are at a higher risk for complications from numerous infectious diseases, including severe viral respiratory tract infections, such as those caused by SARS-CoV-2 (COVID), influenza and adenovirus. For example, diabetic patients account for over 30% of the hospitalizations from influenza and are more likely to have worse clinical outcomes from other severe viral respiratory tract infections. Survival from these severe infections often results in altered lung structure which can impair lung function and increase the long-term risks of pneumonia, hospitalization, and death in diabetic Veterans. The goal of this project is to develop a diabetic animal model to study the basic mechanisms of the damaging inflammation associated with human respiratory virus-induced lung injury in diabetics. This increased understanding can be used as a basis for advances in therapeutic interventions to prevent related short-term and long-term lung dysfunction in Veterans.